The function of GABA/glutamate co-release in the habenula

ABSTRACT:
Balance of excitation and inhibition is critical for proper function of the nervous system. In many brain regions,
there is feedforward and feedback inhibition from interneurons that release the inhibitory transmitter GABA to
balance the release of excitatory glutamate from long-range inputs. However, in the lateral habenula (LHb) - a
key component of the brain's reward system – there is little, if any, feedforward or feedback inhibition and few
inhibitory neurons. Instead, our work suggests that excitatory/inhibitory balance is achieved, at least partly, by
co-release of GABA with glutamate from individual inputs arising from the globus pallidus (GPi), a major input to
the LHb. The activity of GPi inputs to the LHb and the activity of LHb neurons affect motivational vigor. They are
also phasically excited by negative environmental feedback and phasically inhibited by positive environmental
feedback, which guide learning. Rats with low motivation and negatively biased feedback sensitivity have
elevated LHb activity and unbalanced GABA and glutamate signaling from the GPi to LHb. Based on these
observations, we believe that GABA/glutamate balance from GPi to the LHb is important for (1) regulating tonic
(basal) LHb activity and motivational vigor, and (2) bidirectional phasic signaling of negative and positive
feedback in the LHb and behavioral sensitivity to negative and positive feedback. The objective of this grant is
to test these hypotheses by artificially manipulating GABA/glutamate balance from GPi to LHb in mice and
measuring (1) tonic LHb activity and motivation, and (2) phasic LHb responses and behavioral sensitivity to
negative feedback (reward omission) and positive feedback (reward). Based on studies of GABA/glutamate co-
release in the hippocampus, we further hypothesize that long-term changes in tonic and/or phasic LHb activity
will induce homeostatic plasticity of GABA/glutamate co-transmission from the GPi to LHb. We believe this study
is significant because it will reveal the relationship between excitatory/inhibitory balance and fundamental
motivational and learning processes that are affected in many psychiatric disorders, while also investigating the
function of GABA/glutamate co-transmission.

Public health relevance
PROJECT NARRATIVE: The proposed research is relevant to public health because it will provide fundamental knowledge about a brain region involved in psychiatric disorders, including depression and addiction. Upon conclusion, we will understand the role of excitation/inhibition balance in activity regulation of the lateral habenula. This discovery will stimulate new therapeutic avenues directed at restoring excitation/inhibition balance in psychiatric disorders.